Genetic Control of Respiratory Motor Circuit Development, Connectivity and Maintenance

Project Summary/Abstract
Breathing is a vital motor behavior which is controlled by neural circuits within the brainstem and spinal
cord. Degeneration of these circuits leads to respiratory disorders, such as central sleep apneas, and,
eventually, respiratory failure. In mammals, contraction of the diaphragm muscle is essential for driving airflow
into the lungs during inspiration. At the core of respiratory circuits are Dbx1-derived interneurons in the
brainstem, which generate the rhythm and pattern of breathing, and phrenic motor neurons (MNs) in the spinal
cord, which provide the final motor output that drives diaphragm muscle contractions during inspiration. Despite
their critical function, the principles that dictate how respiratory circuits assemble are largely unknown. We
have found that sustained activity of Hox5 transcription factors is required in both phrenic MNs and Dbx1-
derived brainstem neurons to generate normal breathing behaviors and robust respiratory motor output. In this
proposal we will investigate the function of Hox5 genes in determining respiratory neuron specification,
connectivity and maintenance.
In Aim 1 we will define how Hox5 gene expression underlies the specification and connectivity of Dbx1-derived
brainstem neurons at distinct time points.
In Aim 2 we will test the hypothesis that sustained, cell-autonomous Hox5-dependent programs drive and
maintain phrenic MN connectivity.
In Aim 3 we will utilize a novel mouse model to define the molecular mechanisms that control the specification
and development of brainstem respiratory neurons.
We have developed an integrative methodology combining genetic models, next-generation
sequencing approaches, retrograde viral tracing, and electrophysiology to address these questions in vivo. The
overarching goal of this proposal is to uncover the basic principles underlying respiratory circuit assembly so
that we can begin to consider alternative treatment methods for respiratory dysfunction.

Public health relevance
Project Narrative Respiratory failure is the leading cause of death in common neurodegenerative diseases like Amyotrophic Lateral Sclerosis (ALS) and neurodevelopmental disorders such as Sudden Infant Death Syndrome (SIDS) and Rett Syndrome. These disorders are caused by disruptions in the connections between neurons in the central nervous system and the muscles that control breathing. The goal of this proposal is to understand the molecular mechanisms that control the development and connectivity of respiratory neurons, in an effort to identify effective treatment methods for breathing disorders.